Fabrication of Nanoscale Plastics and Effects on Intestinal Barrier Function In Vitro

PROJECT SUMMARY/ABSTRACT
The overarching goal of this proposed R21 program is to fabricate well-characterized nanoplastics (NPs)
comprising high-commodity plastics and to investigate the impact of these NPs on intestinal barrier
function in vitro. This proposed research addresses the numerous reports showing that drinking water,
beverages, and food products contain small-scale fragmented plastics (microplastics or MPs and likely
NPs) consisting of high-commodity plastics (e.g., polyethylene terephthalate [PET], polyamide [Nylon],
high- and low-density polyethylene [HDPE and LDPE, respectively], polypropylene [PP]). However, current
conclusions concerning the effects of NPs on biological systems are primarily deduced from studies using
commercially available polystyrene (PS), which does not represent the breadth of globally dominant
plastics. Unfortunately, NPs derived from the most common globally manufactured polymers are
unavailable, either commercially or via fabrication routes, thereby impeding biological studies similar to
those already performed with PS. This R21 program addresses the critical need for scientific data to
understand human health risks from the unintentional ingestion of NPs, a need that has been emphasized
by both the World Health Organization and European Food Safety Authority. We will design and develop
well-characterized NPs comprising globally ubiquitous plastics that have not been fabricated previously or
tested in mammalian cells or animal models before. Our design strategy will ensure that the fabricated
NPs are appropriate for systematic biological studies that require tracers, tight particle size distributions,
and well-characterized compositions. Our approach will result in the first studies using in vitro models to
examine how NPs derived from the most common high-commodity plastics affect intestinal barrier
function. The overarching hypothesis is that NPs comprising globally ubiquitous plastics can interact with
the intestinal barrier and affect the barrier function of the small intestinal tract. We propose two specific
aims: (1) develop highly characterized NPs comprising high-commodity plastics that are suitable for
assessment in biological systems and (2) evaluate NP digestion, translocation, and interference with the
small intestinal tract in vitro. To assess the human health risk of NPs, scientific data are needed, and
investigating the impact of digested NPs on intestinal barrier function is a critical first step. This R21
program is milestone-driven and provides defined deliverables to support steps toward understanding how
the unintentional ingestion of NPs affects human health.

Public health relevance
PROJECT NARRATIVE Particles of high-commodity plastics have been reported in the food chain and human stool, but with the exception of polystyrene, well-characterized nanoplastics (NPs) of these plastic types are currently unavailable. The most common plastic particles detected in the food chain are derived from high-commodity plastics (e.g., polyethylene terephthalate [PET], polyamides [Nylon], high-density and low-density polyethylene [HDPE and LDPE, respectively], and polypropylene [PP]). We will address this critical need by fabricating highly characterized NPs comprising these high-commodity plastics to understand how the oral ingestion of these types of NPs impacts human health, focusing on the interaction between NPs and the human intestinal tract.